Development of soluble and membrane bound immunogens to shepherd HIV-1 MPER specific BCR maturation

The quest for a broadly protective vaccine against Influenza has been stymied in part to the antigenic diversity of the flu virus, and in part due to pre-existing, non-protective immunity from past exposures, so called immunological imprinting. Further complicating the elicitation of broadly protective antibodies against Influenza is that the most highly immunodominant regions of hemagglutinin tend to be in regions of high antigenic variability, which generally only result in strain specific or seasonal responses [1]. In recent years, multiple groups have isolated antibodies directed towards highly conserved regions of hemagglutinin located in the stem [2-4], including towards the newly identified anchor epitope, which is analogous to the membrane proximal external region (MPER) of the HIV-1 envelope protein. These broadly neutralizing anchor antibodies have exhibited the ability to bind and neutralize H1, H2 and H5 viruses [5, 6]. Thus, anchor bnAbs are an attractive class of antibodies for passive infusion or vaccine elicitation, either in isolation or in concert with other epitopes where they would likely enhance protection breadth. Though the stem region of hemagglutinin tends to be more conserved, the recessed and immunologically subdominant nature of the epitope restricts the frequency of these responses, however the development of epitope scaffold immunogens could overcome these barriers for antibody access. Rigorous prior research has demonstrated (i) germline targeting epitope scaffolds can elicit highly specific antibodies against HIV in both preclinical and clinical models [7-11]; (ii) influenza neutralizing antibodies are influenza correlates of protection [12-14]; and (iii) tuning Influenza humoral responses towards conserved regions can improve cross strain reactivity of elicited responses [6, 15]. This project seeks to develop immunogens that present the anchor epitope in a native-like context with the aim of eliciting anchor class antibodies.

Public health relevance
Development of a broadly protective vaccine against Influenza is a global health priority. Estimates put the annual number of Influenza infections at roughly one billion cases, resulting in 650,000 fatalities [16]. The present strategy of seasonal influenza vaccination result in variable efficacy (as low as 19% during the 2014-2015 flu season) [17] and provide negligible protection against emerging zoonotic or potential pandemic strains [18]. For this reason, it is highly desirable to develop a broadly protective vaccine to elicit antibodies directed towards highly conserved regions of influenza glycoproteins that would exhibit cross strain reactivity and neutralization [19-21]. References Heaton, N.S., et al., Genome-wide mutagenesis of influenza virus reveals unique plasticity of the hemagglutinin and NS1 proteins. Proc Natl Acad Sci U S A, 2013. 110(50): p. 20248-53. Lang, S., et al., Antibody 27F3 Broadly Targets Influenza A Group 1 and 2 Hemagglutinins through a Further Variation in V(H)1-69 Antibody Orientation on the HA Stem. Cell Rep, 2017. 20(12): p. 2935-2943. Ekiert, D.C., et al., Antibody recognition of a highly conserved influenza virus epitope. Science, 2009. 324(5924): p. 246-51. Dreyfus, C., et al., Highly conserved protective epitopes on influenza B viruses. Science, 2012. 337(6100): p. 1343-8. Guthmiller, J.J., et al., Broadly neutralizing antibodies target a haemagglutinin anchor epitope. Nature, 2022. 602(7896): p. 314-320. Andrews, S.F., et al., An influenza H1 hemagglutinin stem-only immunogen elicits a broadly cross-reactive B cell response in humans. Sci Transl Med, 2023. 15(692): p. eade4976. Leggat, D.J., et al., Vaccination induces HIV broadly neutralizing antibody precursors in humans. Science, 2022. 378(6623): p. eadd6502. Jardine, J.G., et al., Priming a broadly neutralizing antibody response to HIV-1 using a germline-targeting immunogen. Science, 2015. 349(6244): p. 156-61. Jardine, J.G., et al., HIV-1 broadly neutralizing antibody precursor B cells revealed by germline-targeting immunogen. Science, 2016. 351(6280): p. 1458-63. Correia, B.E., et al., Proof of principle for epitope-focused vaccine design. Nature, 2014. 507(7491): p. 201-6. deCamp, A.C., et al., Human immunoglobulin gene allelic variation impacts germline-targeting vaccine priming. NPJ Vaccines, 2024. 9(1): p. 58. Ng, S., et al., Novel correlates of protection against pandemic H1N1 influenza A virus infection. Nat Med, 2019. 25(6): p. 962-967. Petrie, J.G., et al., Evaluation of correlates of protection against influenza A(H3N2) and A(H1N1)pdm09 infection: Applications to the hospitalized patient population. Vaccine, 2019. 37(10): p. 1284-1292. Krammer, F., The human antibody response to influenza A virus infection and vaccination. Nat Rev Immunol, 2019. 19(6): p. 383-397. Corbett, K.S., et al., Design of Nanoparticulate Group 2 Influenza Virus Hemagglutinin Stem Antigens That Activate Unmutated Ancestor B Cell Receptors of Broadly Neutralizing Antibody Lineages. mBio, 2019. 10(1): p.e02810-18. Iuliano, A.D., et al., Estimates of global seasonal influenza-associated respiratory mortality: a modelling study. Lancet, 2018. 391(10127): p. 1285-1300. Zimmerman, R.K., et al., 2014-2015 Influenza Vaccine Effectiveness in the United States by Vaccine Type. Clin Infect Dis, 2016. 63(12): p. 1564-1573. Krammer, F. and P. Palese, Advances in the development of influenza virus vaccines. Nat Rev Drug Discov, 2015. 14(3): p. 167-82. Krammer, F., A. Garcia-Sastre, and P. Palese, Is It Possible to Develop a "Universal" Influenza Virus Vaccine? Potential Target Antigens and Critical Aspects for a Universal Influenza Vaccine. Cold Spring Harb Perspect Biol, 2018. 10(7): p. a028845. Andrews, S.F., et al., Is It Possible to Develop a "Universal" Influenza Virus Vaccine? Immunogenetic Considerations Underlying B-Cell Biology in the Development of a Pan-Subtype Influenza A Vaccine Targeting the Hemagglutinin Stem. Cold Spring Harb Perspect Biol, 2018. 10(7): p. a029413. Wei, C.J., et al., Next-generation influenza vaccines: opportunities and challenges. Nat Rev Drug Discov, 2020. 19(4): p. 239-252.